Bat pluripotent stem cells as a novel experimental system

Bats are perhaps the most fascinating but least understood mammalian order. It is clear
that, although bats are a critically needed new model organism, limited access to animal
and cell models has hindered their study. We recently generated the first induced
pluripotent stem cells (iPSCs) from a bat (R. ferrumequinum) and discovered that bat
iPSCs had a unique transcriptomic profile enriched in metabolomic and immune
pathways ketogenic metabolism and a unique inflammasome response. We plan to
generate additional to test if our novel protocol can be used for any bat species and that
essential metabolic genes uniquely expressed only in bat cells, including HMGC2, can
be knocked out using CRISPR/Cas9. We will also evaluate if the inflammatory response
is altered in myeloid cells derived from bat iPSCs. Bat stem cell lines and differentiated
progeny will help address bat physiology’s most tantalizing questions, including
immunity.

Public health relevance
We have generated the first induced pluripotent stem cells (iPSCs) from a bat and discovered that these cells have unique properties relative to other mammalian iPSCs. Our research will provide novel insights into the molecular basis of bats’ unique native immunity.